IGF::OT::IGF PURPOSE: TO ALLOT THE FUNDS FOR THE BASE PERIOD FOR :NIH PAIN CONSORTIUM CENTERS OF EXCELLENCE IN PAIN EDUCATION POP: 09/17/2015-09/16/2016

In an effort to help improve pain treatment while reducing the prescription pain medication epidemic, the NIH Pain Consortium will continue to create initiatives to increase pain education in medical, nursing, pharmacy, and dental schools across our nation.